Practical Approaches to Care in Emergency Syncope (PACES)

Project Summary/Abstract
Syncope (or transient loss of consciousness) is a common reason to present to the ED, representing over 1.3 million
visits per year in the United States. Although syncope is most often benign, it can occasionally be caused by serious
cardiac diseases such as cardiac dysrhythmia, valvular heart disease, or other structural heart disease. Despite thorough
evaluation in the ED, the cause of syncope remains unknown in over 50% of cases. The goal of this project is to use
artificial intelligence-electrocardiogram (ECG) models to improve the diagnosis of cardiac disease for patients who
present to the emergency department (ED) with syncope, by better delineating which patients require further cardiac
testing, such as echocardiography or prolonged cardiac monitoring.
Artificial intelligence (AI) models, using machine learning approaches, have been developed using retrospective ECG
data to predict valvular heart disease and, more broadly, any structural heart disease. The first model, known as
ValveNet, is highly accurate at predicting mitral regurgitation, aortic stenosis, and aortic regurgitation. The second
model, known as EchoNext, is highly accurate at predicting all forms of structural heart disease as diagnosed by
echocardiography, including valvular heart disease, ventricular systolic dysfunction, left ventricular hypertrophy, and
significant pericardial effusions. While promising, these two AI models require external validation prior to clinical
implementation. In Aim 1 of this proposal, we use prospectively collect data on ~1,012 ED patients with syncope/pre-
syncope to validate the predictive accuracy of these two AI models in detecting valvular and structural heat disease,
including mitral valve prolapse, using echocardiography as our gold standard. In Aim 2, we will assess the whether
baseline valvular heart disease is an independent risk factor for serious cardiac events, such as acute cardiac
dysrhythmias, at 30 days among ED patients with syncope.
If validated and shown to accurately predict valvular and structural heart disease, these artificial intelligence models
could play a major role in improving emergency syncope care by rapidly identifying patients who require
echocardiography and/or prolonged cardiac monitoring. This would, in turn, lead to expedited medical and surgical
therapy to reduce cardiac morbidity and mortality. This study, entitled SyncopeNet, will help improve clinical care for
patients with syncope and advance the field of syncope research.

Public health relevance
Project Narrative Syncope, or transient loss of consciousness, is a common reason for visit to the Emergency Department and can be caused by a variety of cardiac conditions including valvular heart disease, such as mitral valve prolapse, and other types of structural heart disease. Our study will evaluate the ability of two artificial intelligence models, using data from the electrocardiogram, to predict the presence of structural heart diseases, including mitral and other valvular diseases, on echocardiogram and their association with future cardiac events. If validated, these models could revolutionize the way these cardiac conditions are diagnosed, thus improving the quality of care for the 1-2 million patients who experience syncope every year in the United States.